Tertiary Lymphoid Organs in Transplantation

Abstract
In solid organ transplantation, immunosuppressive therapy has significantly improved short-term organ allograft
survival by reducing acute rejection rates. However, chronic rejection - mediated by T cells, antibodies (Abs), or
both - has not declined in incidence and remains an important obstacle to long-term allograft survival. A likely,
important contributor to the pathogenesis of chronic rejection is the formation of tertiary lymphoid organs (TLO)
within the graft. Evidence that TLO play a causative role in rejection derives from both mice and humans, as TLO
have been documented in a majority of chronically rejected mouse and human allografts, and experimental
models have shown that they support naïve T and B cell activation and influence graft outcome. Moreover,
analysis of human renal allograft biopsies has demonstrated B cell hypermutation and Ab production within TLO.
Together, these studies support the hypothesis that TLO are niduses of local (intragraft) immune activation in
chronic allograft rejection. In Aim 1 of this grant application, we will establish the cause-effect relationship
between TLO and chronic renal transplant rejection in the mouse. In Aim 2, we will investigate the cellular and
cytokine mechanisms responsible for TLO formation in allografts, with particular emphasis on innate lymphoid
cell (ILC) subsets. In Aim 3, we will delineate the specific immunologic functions of TLO in chronic rejection, with
focus on B cell activation and antibody production. The proposed studies address the unmet challenge of treating
and preventing chronic rejection and will also shed light on other conditions in which TLO play a prominent role,
such as autoimmunity and cancer.

Public health relevance
Project Narrative Chronic rejection is a major obstacle to long-term allograft survival. Tertiary lymphoid organs (TLO) have been described in the majority of chronically-rejected allografts, suggesting an important role in this process. This project investigates the mechanisms of TLO formation and their contribution to chronic allograft rejection. Knowledge gained here will inform us of potential novel therapies to control chronic rejection and prolong allograft and patient survival.